Impact of altered sensorimotor experience in robotic training on adaptation of hand muscle coordination of stroke survivors

Abstract
Significant functional impairment of the hand is commonly observed following stroke. Robot-assisted training of
the hand can help stroke survivors practice complex multi-degrees-of-freedom movements of the hand, but it
remains mostly unknown how training conditions affects coordination patterns of the muscles producing hand
movements; such changes are critical in restoring hand function of stroke survivors after the training. The
overall hypothesis of this proposal is that the adaptation of the hand muscles during assisted training, even for
the same type of task, will be significantly affected by the assistance dynamics, sensory feedback, and task
condition.
The goal of this proposal is to examine the impact of the following three conditions of robot-assisted training on
the motor adaptation of the three hand muscle groups (extrinsic extensor, extrinsic flexor, and intrinsic
muscles) of stroke survivors. We will investigate: (1) whether two widely-used assistance mechanisms (end-
effector vs. exoskeleton) induce different patterns of changes in the extrinsic and intrinsic hand muscle
coordination; (2) if sensory modulation of distal and proximal finger joint movements results in different
changes in the muscle coordination; and (3) whether the dynamics of the task performed (static vs. dynamic)
affect these muscle groups differently when assisted.
The proposed study will elucidate the important, but currently not well-understood aspects of robot-assisted
training outcomes, i.e., how altered sensorimotor experience affects motor adaptation of stroke survivors at
their muscle level. We will use a novel robotic setup and virtual-reality technologies to alter sensorimotor
inputs/outputs associated with finger movements of stroke survivors. The results will provide vital information
regarding how the key aspects of robot-assisted training (assistance, feedback, and task dynamics) should be
designed to effectively restore impaired muscle coordination of the hand. In the long term, these outcomes will
lead to therapeutic approaches to restoring hand function of stroke survivors even after the training is
completed.
1

Public health relevance
Project Narrative The goal of this proposal is to understand how different aspects of the robot-assisted training of the hand of chronic stroke survivors can affect their muscle control. First, we will apply two widely-used robot types (end- effector and exoskeleton) to hand movements of stroke survivors, and compare the changes in their muscle use during and after the training with these two devices. We will then examine how two different types of movement feedback (movement amplification or reduction) affect the way stroke survivors control their hand muscles. Finally, we will study if the dynamic condition of the training, i.e., force production or movement, can affect the way they control their hand muscles. The outcome of this study will help us design optimal robotic trainings for the hand of individual stroke survivors, targeting specific problems in their muscle use, which are the very underlying cause of their hand functional impairment. 1